BREAST CARCINOMA CHANGES CAUSED BY ONCOGENE EXPRESSION

The aim of our experiments is to understand the mechanism by which oncogenes, particularly the neu/Her-2 oncogene, cause specific cell-surface oligosaccharide changes in breast carcinoma cells and to determine if these changes affect cell adhesion properties. We and others have established that these oligosaccharide changes are caused by an increase in the activity of a particular glycosyltransferase, N-acetylglucos-aminyltransferase V or GlcNAc-T V. The oligosaccharide products of GlcNAc-T V have been shown to increase on the surfaces of fibroblasts and other cell types following oncogenic transformation. Moreover, the results of experiments from several laboratories suggest that alterations in the expression of these oligosaccharides influence the metastatic potential of cells. It is important, therefore, to understand in breast carcinomas how those oncogenes known to be associated with advanced breast cancer, such as neu/Her-2, alter GlcNAc-T V activity and thereby its oligosaccharide products. We will also determine if these oligosaccharide changes have an effect on the intercellular adhesion of these cells. GlcNAc-T V, the enzyme responsible for synthesizing the critical surface oligosaccharide, has been cloned and transfected into a human carcinoma cell line resulting in the cells' having increased amounts of oligo-N-acetyllactosamine and a more aggressive, cancer-like phenotype. An inducible plasmid has been constructed in which expression of GlcNAc-T V is under control of an unrelated inducer. Preliminary results with stable, inducible transformants resulting from this construct exhibit a fourfold increase in GlcNAc-T V activity following induction.